NLRP10 Inflamasome in Gram-positive Sepsis

ABSTRACT
Sepsis is an important cause of mortality, morbidity, and health care expenditures in immunocompetent
and immunosuppressed populations globally. Sepsis can lead to tissue injury, and eventually results in
tissue dysfunction and subsequent failure. Lower respiratory tract infections are a prominent inducer of
septicemia/sepsis (aka pneumonia-derived sepsis). Antibiotics are common treatments for these
infections. However, the use of these drugs will apply pressure on the bacterium to gain antibiotic
resistance. Therefore, there is a strong need for to broaden our knowledge and the development of new
methods of treatment. In this regard, vigorous recruitment of neutrophils to clear bacteria is a key innate
immune mechanism. Paradoxically, uncontrolled neutrophil leads to extensive tissue damage and organ
failure. In addition to membrane bound Toll-Like Receptors (TLRs), cytosolic NOD-like receptors (NLRs)
serve as critical molecules of innate immunity in pathological settings. Selective NLRs termed
“Inflammasomes” which are key receptors and/or sensors in innate immunity that induce inflammation in
response to invading pathogens. Among inflammasomes, NLR family pyrin domain containing 3 (NLRP3)
is the most studied and has been shown to play an important role during bacterial respiratory infections.
However, the role of NACHT, leucine-rich repeat (LRR), and PYD containing protein 10 (NLRP10) in
Gram-positive pneumonia remains to be delineated because this is a recently identified inflammasome
and does not have a leucine rich domain (LRR). Our lab preliminary data demonstrated that (1)
pneumonic human lungs show upregulated NLRP10 expression in macrophages, neutrophils, and
epithelial cells; (2) mouse lungs display upregulation of NLRP10 in myeloid and structural cells following
sepsis; and (3) NLRP10 knockout (KO) mice show reduced bacterial burden in the lungs and decreased
bacterial dissemination to extrapulmonary organs following Gram-positive infection. Taken together, this
preliminary data led to the hypothesis that the NLRP10 inflammasome is a central regulator of organ
damage in Gram-positive pneumonia-induced sepsis. Two related but independent aims have been
proposed: (1) To delineate the mechanisms by which NLRP10 inflammasome regulates pathogen
clearance during Gram-positive infection; and (2) To determine if ablation of NLRP10 inflammasome can
modulate alveolar macrophage, neutrophil, and alveolar type II epithelial cell function in Gram-positive
infection. The proposed studies will uncover mechanistic insights into the role of NLRP10 on pneumonia-
induced sepsis. The National Research Service Award will enable the PI to gain mentored research
training from a more experienced faculty along with an outstanding dissertation committee in order to
obtain an academic position.

Public health relevance
NARRATIVE Sepsis is a global public health threat. Numerous clinical trials have failed to come out with new therapies. Sepsis is a prominent cause of organ dysfunction and failure in adults and children. Lower respiratory tract infections are a vital cause of septicemia/sepsis (aka pneumonia-derived sepsis). The goal of the project is to explore the innate immune mechanisms associated with pneumonia-derived sepsis in order establish new therapies to reduce multiple organ dysfunction and failure.